Training in Malaria Epidemiology, Translational Research, and Implementation Science to Strengthen Malaria Policy and Control in Uganda

Project summary
This is a renewal application to support training in malaria epidemiology, translational research, and
implementation science to strengthen malaria policy and control in Uganda. Our program has been highly
successful, however, the need for training in malaria research remains great. The high burden of malaria in
Uganda persists, and progress in control has stalled since 2015, with increases in incidence observed the
last few years. Moreover, new challenges have arisen, including the spread of insecticide resistance, the
emergence of artemisinin resistance and the COVID-19 pandemic. In contrast to the magnitude of the malaria
burden in Uganda, the number of malaria researchers remains limited. These observations highlight the need
for continued research that informs optimal malaria interventions, and thus a necessity for the training of
Ugandans to lead this research. We propose to continue our training program, with some adjustments
informed by a comprehensive needs assessment and the new challenges identified. Our long-term goal is to
strengthen capacity to conduct independent and sustainable malaria research at Makerere University to
address challenges of malaria control in Uganda. The objectives of this application are: 1) to expand the
current program to include translational research, genomics and bioinformatics to address the complex
challenges of malaria control; 2) to strengthen institutional capacity of Makerere U in malaria research by
providing Master’s and PhD mentored research training for junior faculty and graduate students; 3) to
substantially increase scientific leadership and expertise needed for independent malaria research in Uganda
through postdoctoral training; and 4) to create sustained growth of malaria research at Makerere U by
strengthening the Malaria Center. We have assembled a strong team of program faculty from Uganda, the
US and Europe already collaborating on several research projects in Uganda, and with extensive experience
in research and higher-level training, to ensure high-quality supervision and mentoring of trainees. Degree
and non-degree training will occur in Uganda and collaborating institutions. In the next five years, we will train
candidates as follows: 1) five in 2-year post-doctoral programs; 2) five in 4-year PhD programs; 3) eight in 2-
year master’s degree programs; and 4) four in a 1–2-year Implementation Science fellowship. Trainees will
be required to take didactic courses, conduct mentored research projects, and acquire professional
development skills through participation in Malaria Center activities. The intended outcomes are: 1)
establishment of a critical mass of Ugandan scientists trained in malaria research; 2) increased malaria
research outputs at Makerere U including scientific publications and new research grants; and 3) increased
dissemination of generated evidence to inform the design and implementation of programs and policies to
control malaria in Uganda. Improved expertise in malaria research will be critical to assist the Ministry of
Health in establishing effective policies for better control and eventual elimination of malaria in Uganda.

Public health relevance
Project Narrative Uganda is currently scaling up proven malaria control interventions, but these efforts are not sufficient to adequately reduce the high malaria burden in the country, and resurgence after discontinuation of control measures has been experienced. These observations highlight an urgent need for continued research that informs optimal malaria interventions, and thus a necessity for the training of Ugandans to lead this research. Improved in-country expertise in epidemiology, translational research, and implementation science will be critical to assist the Ministry of Health in establishing effective policies for the better control and eventual elimination of malaria in Uganda.